Association of genetic variation near the dopamine D2 receptor gene and other polymorphisms that modulate dopaminergic and opioid signaling on the weight loss response to naltrexone/bupropion

PROJECT SUMMARY/ABSTRACT
The cornerstone of obesity therapy - diet, physical activity and behavioral modification - fails to produce sufficient
long-term weight loss in most individuals. Clinical guidelines recommend the addition of anti-obesity medication
(AOM) when conservative methods are less than optimal. Yet even with the use of AOM, there is a wide range
of inter-individual weight loss suggesting that there are “responders” and “non-responders.” The variability in
response to AOMs underscores the heterogeneity of obesity and the need for more personalized treatment that
accounts for individual differences in etiologic factors. Given the strong heritability of obesity, it is possible that
genetic factors play a role in an individual’s response to a given pharmacotherapy. This proposal focuses on
the FDA-approved AOM, Contrave, which is a combination of two medications, naltrexone and bupropion (NB).
Naltrexone is a µ-opioid receptor (MOPR) antagonist and bupropion inhibits the reuptake of dopamine and
norepinephrine. Clinical trials of NB demonstrate a mean weight loss of 6.1% after 56 weeks of treatment;
however, only 48% of patients achieved a clinically significant reduction in body weight of ³5%. Knowledge of
the likely mechanisms of action of NB makes it possible to address what might underlie the variability in response.
The bupropion component activates the proopiomelanocortin (POMC) neuron, a key regulator in decreasing food
intake and stimulating energy expenditure, and occurs in part through stimulation of dopamine D2 receptors
(DRD2). Naltrexone also activates POMC neurons by binding MOPR. We postulated that some of the variability
in response to NB may be due to the Taq1A genetic variant (rs1800497) located in the ankyrin repeat and kinase
domain-containing protein 1 (ANKK1) gene, adjacent to the DRD2 gene. Individuals carrying at least one minor
allele of the rs1800497 polymorphism (termed Taq1A A1+) represent about 45% of the population and have 30-
40% fewer brain DRD2. Such individuals likely have a relative deficiency in dopaminergic activation of POMC
neurons, thus, we predict they would receive the greatest benefit from a drug that remedies this deficit. With this
hypothesis in mind, we conducted a proof-of-concept pilot study reviewing charts of patients treated with NB and
indeed found that carriers of the Taq1A A1+ genotype had a greater weight loss response compared with non-
carriers, suggesting that this genotype could be used to predict successful weight loss. In Aim One, we propose
to rigorously test the hypothesis that presence of the Taq1A A1+ polymorphism is associated with greater weight
loss with NB compared with the A1- genotype. Maintenance of weight loss after discontinuation of drug treatment
will also be evaluated. In Aim Two, we will explore other genetic polymorphisms that might influence the efficacy
of NB and determine if serum prolactin level, a measure of central dopaminergic tone, may be used as a systemic
biomarker to help predict drug response. The ultimate goal is to incorporate pharmacogenetics into obesity
medicine in order to maximize results and limit unnecessary cost and exposure to side effects of medications
that provide minimal benefit to the individual patient.

Public health relevance
PROJECT NARRATIVE The use of anti-obesity medication (AOM) is recommended when conservative methods fail to achieve and maintain sufficient weight loss. Yet even with the use of AOM, there is a wide range of inter-individual weight loss suggesting that there are “responders” and “non-responders.” The purpose of this study is to determine if genetic biomarkers can be used to better predict the weight loss response to combination therapy with naltrexone/bupropion, an FDA-approved AOM, and thus, open up the field of pharmacogenetics to obesity treatment.